GH RESPONSE TO IV ADMINISTRATION OF GHRP AND GHRH IN GH DEFICIENT MEN

Response to an ITT will be correlated with spontaneous GH secretion and GH responses to iv GHRP and GHRH in GH deficient men. GHRP offers a new dimension in testing the hypothalamic/pituitary axis and may help determine which GH deficient children would benefit from GHRP and GHRH treatment.